DESTRUCTIVE LUNG DISEASE

There are 2 million individuals in the U.S.A with emphysema. Two percent develop the disease because of inheritance of a deficiency of alpha 1-antitrypsin (AAT), an antiprotease that protects the lower respiratory tract from destruction mediated by elastase released by neutrophils. Oliginucleotides have been used to detect specific mutations in the AAT gene. The "null" AAT state is asociated with an intact gene but no detectable AAT mRNA. Alveolar macrophages produce AAT, thus providing the protein at the site of disease. Site directed mutagenesis has been used to produce a recombinant AAT molecules in E.coli that is oxidation resistant. Therapy of AAT deficiency purified from pooled plasma has demonstrated that the anti-neutrophil-elastase defenses of the lung can be reestablished with intermittent intraveneous administration of 60 mg/kg AAT.